DEVELOPMENT OF A WNT PATHWAY INHIBITOR FOR METASTATIC COLORECTAL CANCER

ABSTRACT Colorectal cancer (CRC) represents the fourth most commonly diagnosed cancer with 134,490 new cases each year. Unfortunately, CRC results in a disproportionate number of deaths (49,190 projected in 2016) due to advanced stage at diagnosis, the aggressive phenotype of the disease and lack of effective therapeutics. Greater than 90% of CRC patients possess activating mutations in the WNT signaling pathway. WNT pathway activation is a critical step in the initiation of CRC tumorigenesis. Currently, there are no FDA-approved drugs or drugs in late-stage clinical trials that target the WNT pathway. As a result, here is an urgent need for the development of inhibitors of the WNT pathway to treat not only CRC, but other WNT-driven cancers. StemSynergy Therapeutics Inc. (SSTI) is a biopharmaceutical company focused on the discovery, development and commercialization of novel therapeutic approaches to target critical cancer stem cells, including WNT, Hedgehog and Notch. SSTI has identified a class of small molecules that regulate WNT signaling via activation of Casein Kinase 1?? In this application, we describe detailed characterization of mechanism of action, demonstrate SST-215 functions downstream of activating mutations found in CRC to produce excellent in vitro potency in a range of CRC cell lines and provide significant in vivo efficacy data using various genetic and xenograft models in mice. Significantly, SST-215 does NOT affect normal GI architecture, which is in contrast to two other major classes of WNT inhibitors currently being developed where GI toxicity is dose limiting. This Phase IIb application outlines the next logical steps in the development of SST-215: completion of rodent and non-rodent safety studies, IND preparation and initiation of a Phase I clinical trial for advanced or metastatic cancer. Successful completion of this Phase IIb project will provide all of the necessary studies for progression to proof-of-concept Phase II efficacy study in humans and accomplish the mission of the SBIR program of supporting small businesses in bringing forward innovative solutions to major public health concerns. The WNT pathway plays a role in many different cancer subtypes and because there are no drugs on the market that target the WNT pathway, by continuing to move SST-215 through the oncology development pipeline, SSTI has the potential to improve and prolong the lives of millions of cancer patients worldwide. The multi-disciplinary R&D team at SSTI has strong credentials and experience in all relevant areas, enabling us to complete the key science and business aspects of the development. As part of our commercialization plan, SSTI is collaborating with Geneyus, LLC (funded by Three Seasons Capital) to provide matching funds for this application, as well as significant follow-on commercialization funding contingent on SSTI meeting the milestones outlined herein. In summary, we provide strong preclinical data supporting the molecular targeting, therapeutic efficacy and preliminary safety studies for SST-215 justifying transition to the next stages of development, non-human primate safety studies and a phase I clinical trial. Support of this Phase IIb application will ensure that SST-215 does not succumb to delays in development due to funding and will support SSTI bringing to market a first generation of WNT inhibitors to capture a significant share of the global market for cancer drugs.

Public health relevance
PROJECT NARRATIVE Colorectal cancer is usually an aggressive and deadly disease with limited treatment options. The Wnt pathway is a major growth pathway that plays a critical role in >90% of all cases and there are currently no inhibitors in the clinic. We intend to develop our lead compound Wnt pathway inhibitors through pre-clinical and clinical trials for a treatment of colorectal cancer.